Administration Core

PROJECT SUMMARY - ADMINISTRATION CORE
The LONI Resource (LONIR) has grown and matured since 1998, when it was initially funded. Administrative
functions include measuring, tracking and reporting scientific publications, collaborations, community services,
educational activities and web resource activity. To manage the existing LONIR infrastructure and support the
proposed developments, we have established an efficient and comprehensive administrative structure.
Specifically, the main responsibilities of the Administration Core are; allocation of resources, budgetary
control, tracking and monitoring, policy, operations and implementing SAB recommendations. A pivotal
LONIR guiding principle is the resource's collaborative and open nature. Appropriate rules of governance are
important components to its success. The structure of our Biomedical Technology Resource Center (BTRC) is
comprised of three Technology Research and Development (TR&D) projects, coupled to a national distribution
of innovative and meritorious collaborative projects (CPs) that both push and pull the TR&D technologies. The
LONIR supports numerous, service projects (SPs) that access the advanced technologies developed in the
TR&Ds and trains users and disseminates technologies in an open and accessible way. LONIR is administered
by competent and experienced investigators and staff. Finally, a fully engaged and expert panel of scientists –
our SAB – provides advice and counsel on all aspects of this BTRC.

Public health relevance
PROJECT NARRATIVE - ADMINISTRATION CORE The operations of any successful program must be codified and structured so that the various elements, entities and activities of the program work in concert to produce outstanding, ethical and responsible science. The administrative core of the LONIR serves these functions.